Dietary Predictors of New-Onset Diabetes following Acute Pancreatitis in the DREAM Study.

Project Summary/Abstract:
This is an application for a K01 award for Djibril M. Ba, PhD, MPH, an assistant professor at the Penn State
College of Medicine in the Department of Public Health Sciences. Dr. Ba is uniquely qualified to conduct this
research project based on a strong foundation in nutritional epidemiology for examining diets in relation to
disease occurrence. The proposed K01 application will provide Dr. Ba protected time, which will be devoted
towards training and career development activities targeting the following objectives to strengthen Dr. Ba's
trajectory toward becoming a successful independent investigator: (1) Acquire knowledge and expand didactic
learning; (2) Gain advanced quantitative skills required for developing different dietary indices and analyzing
longitudinal dietary data from epidemiologic studies; (3) Enhance Dr. Ba translational grantsmanship and
leadership skills to effectively compete for future NIH funding; and (4) Obtain the knowledge base and
professional skills to perform Data Coordinating Center activities. Dr. Ba has assembled a mentoring team
comprised of a primary mentor, Vernon M. Chinchilli, PhD a leading expert in the field of biostatistics and Data
Coordinating Centers, and three co-mentors: Dr. Phil Hart (gastroenterologist), Dr. Qi Sun (nutritional
epidemiologist), and Dr. Nazia Raja-Khan (endocrinologist). Healthy plant-based and Mediterranean diets,
which are based on high consumption of antioxidant-rich foods such as fruits and vegetables, have been
associated with a lower risk of diabetes in the general population. In contrast, pro-inflammatory diets such as
those reflected by a high empirical insulinemic index and a high empirical dietary inflammatory index including
red and processed meats, may lead to an increased risk of diabetes. These dietary components are known to
be positively associated with endothelial dysfunction, inflammation, insulin resistance, and oxidative stress that
can cause tissue damage, especially reduced pancreatic β-cell function. Almost one-third of patients with acute
pancreatitis (AP) will develop diabetes within 3 years but it is unclear whether the risk is based on dietary
patterns. This constitutes a critical knowledge gap regarding the effects of different dietary patterns on the
prevention of diabetes following AP and whether such risk can be mitigated. The overall objective of this
application is to acquire detailed knowledge and novel research skills needed to accomplish the following
research aims: Aim 1: To prospectively determine the role of dietary patterns in the development of diabetes
(primary outcome) or pre-diabetes (secondary outcome) following an episode of AP; Aim 2: To determine the
associations of dietary patterns with weight changes, waist circumference, and biomarkers of metabolic
alterations related to diabetes; Aim 3: To determine whether weight changes and biomarkers of metabolic
alterations are mediators for the association between dietary patterns and the risk of new-onset diabetes
among AP participants in the DREAM study. Findings from this project will provide strong evidence about the
role of dietary patterns on the occurrence of future diabetes following AP.

Public health relevance
Project Narrative This proposed K01 application seeks to compare different dietary patterns and determine which ones may be better suited for diabetes prevention among high-risk acute pancreatitis (AP) patients in the NIH-funded Diabetes RElated to Acute Pancreatitis and its Mechanisms (DREAM) study. This study will provide a novel understanding of the critical role of different dietary patterns in preventing new-onset diabetes following AP. It also opens new potential avenues for research into the pathophysiological mechanisms by which dietary patterns affect this risk, as currently being investigated in the DREAM study.